Immunological and Microbial Mechanisms in Food Allergy

ABSTRACT
The high prevalence of food allergy (FA) places many at risk of severe reactions to foods including anaphylaxis
(1). Our studies on human subjects with FA and in relevant mouse models have identified changes in regulatory
T (Treg) cell populations as playing a pivotal role in disease pathogenesis. Specifically, we have identified a
critical role of RORgt+ Treg cells, induced by the gut commensal bacteria, in mediating oral tolerance to food
allergens (2, 3). In contrast, FA is associated with defective microbiota-dependent differentiation of RORgt+ Treg
cells due to dysbiosis. We identified Resistin like molecule beta (RELMβ), a gut goblet cell cytokine previously
linked to the innate immune response to parasitic infections (4-6), as pivotal to FA pathogenesis by promoting
dysbiosis and disrupting RORgt+ Treg cell differentiation. Reciprocally, there emerges in FA food allergen-specific
Treg cells with a T helper cell type (Th2) cell like phenotype, with high expression of the transcription factor
GATA3 and the Th2 cytokines IL-4 (7, 8). These reprogrammed Treg cells play an essential role in amplifying
disease pathology, and they decline in patients receiving oral immunotherapy (7, 8). Our recent analysis of
circulating Treg cells of human subjects with FA identified Thymic stromal lymphopoietin receptor (TSLPR) as a
marker of their Th2 cell-like reprogramming. Accordingly, the focus of this proposal is to identify immune
regulatory checkpoints that govern FA and means of resetting them to promote oral tolerance. Our overall
hypothesis is that the evolution of FA entails two critical checkpoints each involving a distinct Treg cell population
under control of dedicated innate cell and cytokine circuits. The first involves microbiota-dependent Helios–
RORgt+ Treg cells generated at the peri-weaning period and thereafter which enforced oral tolerance. This circuit
is negatively controlled by RELMb, itself induced by an upstream Tuft cell (IL-25)-ILC2(IL-13) axis (9-11), which
predisposes to FA by promoting dysbiosis. The second involves Helios+TSLPR+ Th2 cell-like Treg cells that are
positively regulated by IgE/Mast cells and which augment the FA responses. To explore this hypothesis, we will
under Aim 1 examine the evolution of the pro-tolerogenic immune response in FA Il4raF709 mice following therapy
with anti-RELMb mAb or the acute deletion of the RELMb gene Retnlb. We will also elucidate the mechanisms
by which RELMb antagonism resets the gut microbiota to enforce oral tolerance, including the expansion of
Lactobacilli species rich in indole metabolites that act via the aryl hydrocarbon receptor (AhR) to suppress FA
by inducing RORgt+ Treg cells. Under Aim 2, we will dissect the role of TSLPR on Th2 cell-like reprogrammed
Treg cell in disease pathogenesis. These findings will then be extending to studies under Aim 3 on FA subjects
to relate changes in serum RELMb and Treg cell populations to dysbiosis and disease severity. The proposed
studies will provide fundamental new insights relevant to disease pathogenesis and novel therapeutic
approaches to re-establish oral tolerance in FA.

Public health relevance
Project Narrative Food allergy is a serious and rapidly growing public health concern and the lack of a thorough understanding of disease mechanisms has adversely affected the development of highly effective therapies. Our proposed studies examine how a gut protein named resistin like molecule beta (RELMb) acts to disrupt immune tolerance to ingested foods to result in food allergy. We will also determine how targeting this protein can reset the immune system towards tolerance of ingested food allergens and these studies will allow the development of novel, effective therapies and prevention strategies to aid patients with food allergy.